Idaho INBRE Program

Project Summary/Abstract Overall Component
The Idaho INBRE-5 Program will continue to augment and strengthen Idaho's capacity to do and sustain
biomedical research. The Overall component describes our progress and organization management plan for
an Administrative Core, a Student Research Program, a Developmental Research Project Program, a
Data Science Core, and an Alteration and Renovation request. These components will assist investigators
to obtain independent grants and provide research experiences to students as a pipeline to health research
careers. Activities will promote broad inclusion and multidisciplinary research. The PD/PI, CH Bohach, has 22+
years of experience administering INBRE, has an active distinguished scientific research career, and serves on
the National Committee of the National Association of IDeA PIs. The Program Coordinator, SA Minnich, has
14+ years of experience in this position and a strong record as a biomedical researcher and faculty mentor.
The Administrative Core Management Group provides seasoned organizational, financial, and evaluation
support. The Program and Core Directors have the experience, time commitment, resources, and authority to
manage their respective scientific responsibilities. All 12 Network institutions are represented on the statewide
Steering and Executive Committees. An expert External Advisory Committee, chosen for their mentoring,
research expertise, grantsmanship, and administrative skills, will help identify best practices and guide the
Program. Every participating institution has made commitments to support INBRE-5. Such diverse institutional
cooperation across Idaho was unprecedented before INBRE and has far-reaching positive significance for the
INBRE Network to continue research capacity building. It demonstrates that INBRE is maximizing the potential
to catalyze institutional changes that improve biomedical research and education on each campus.
Undergraduate and graduate educational improvements will include science course/program modernization,
integration of research and data science into the curriculum, scientific seminar programs, and purchase of key
laboratory equipment. Resources will contribute to faculty start-up funding and salary augmentation. A
Regional Alliance of INBRE Networks (RAIN) includes all IDeA states in the Western region (AK, HI, ID, MT,
NM, NV, WY) and forges interstate cooperation to reduce program redundancies, maximize Core usage,
promote multidisciplinary research, and expand faculty and student research/educational opportunities.
INBRE-5 will continue to share and leverage resources with other appropriate IDeA programs (INBREs,
COBREs, CTRs, Bridges), NSF-EPSCoR, and Idaho industries. Our commitment to continue and expand the
Network through these interactions is evidenced by the 47 Letters of Support and 11 institutional MOUs in
this proposal. Each supporting document outlines collaboration, partnering, and/or leveraging programmatic
strengths. This INBRE-5 plan will enable faculty and students in rural `frontier and remote' Idaho to participate
in the NIH goal to improve the health of the nation through research.

Public health relevance
PROJECT NARRATIVE INBRE-5 will increase Idaho’s competitiveness in biomedical research and education. The statewide scientific Network will generate, complement, and enrich Idaho’s research capacity by mentoring new investigators, supporting research Cores, fostering regional collaborations, and providing student research opportunities.